Rapid response for pandemics: single cell sequencing and deep learning to predict antibody sequences against an emerging antigen

ABSTRACT
One of the “holy grails” in immunology is to be able to directly predict tight-binding variable chain antibody
sequences in silico against foreign or non-self `antigenic' proteins. Immunoglobulin chain rearrangement can
potentially encode approximately 1016 different variants of antibody heavy and light chain sequences. However,
only a small fraction of the sequence space is generally accessed for evolving antibodies against foreign proteins.
The computational challenge is to go from a model of the structure of an antigen to predicting a set of antibody
chain sequences that can bind tightly to the antigen. If solved, it might be possible to move in less than 24 hours
from the first cryo-electron-microscopic structure of a novel viral protein to advance a set of potent antibody-like
molecular candidates for testing. Towards solving this problem, this project aims to develop a deep learning
architecture that will take as input thermodynamic, quantum mechanical (density functional), and local structure-
based network topographical features of the antigens and their cognate antibodies, and will output their
respective binding affinity constants.
We will design a generative adversarial network (GAN), which we think is uniquely suited for regression-based
ML approaches for the immune system, to discover associations between the epitope and the variable chain
features. This approach requires a large data stream of antigen and cognate antibody sequences, which until
recently was difficult to obtain. A recently described single B-cell receptor (BCR) specific tagging method coupled
with single cell deep sequencing (“linking B cell receptor to antigen specificity through sequencing” or LIBRA-
seq) can rapidly isolate and sequence the BCR variable chain coding regions that can bind with high selectivity
to antigenic epitopes.
Towards the specific project goals, in Task 1, LIBRA-seq will be used to rapidly identify and generate candidate
immunoglobulin coding sequences in response to specific linear and nonlinear epitopes (against controls),
chosen through computational/molecular modeling and prioritized with SARS-CoV-2 Spike protein epitopes (but
not restricted to these), injected into a mouse model, to generate large training sets; in Task 2, these training
sets, along with other data sets already available in public databases, will generate a series of structural features
(described above), which will be used to train the GAN; in Task 3, the predicted epitope-antibody interactions
will be validated by direct experiments with synthetic antibody and phage-display systems. Thus, the proposed
strategy combines foundational principles in evolutionary biology, genomics, structural chemistry, and computer
science to the solution of a general biological engineering problem.
Results from this project are expected to lay the foundations for a rigorously tested and fully automated machine-
learning system that could rapidly generate synthetic antibody candidates from the structure of a novel virus
protein, which can enhance the rapid response ability against a future pandemic. The ability to develop targeted
antibody therapy against non-infectious or chronic diseases, and on the production of antibody-based industrial
enzymes, will also be dramatically enhanced if this project were to be successful.
The team: The team-leads of this multi-institutional research project comprise a computer scientist, a protein
crystallographer, an immunologist, and a molecular biologist.
1

Public health relevance
NARRATIVE The readiness for a future viral pandemic will critically depend on being able to accurately predict, entirely using computers, neutralizing antibody structures directly from the virus's protein structure. Vaccines and therapeutics can then be manufactured and tested with unprecedented rapidity. We propose to make this goal a reality by engaging the advantages of single-cell genomic deep sequencing and the latest advances in deep machine learning.